Promoting Clinical and Translational Science Training and Career Development for Residents

PROJECT SUMMARY
The goal of this Stimulating Access to Research in Residency (StARR) proposal is to recruit, train, and
mentor a multidisciplinary group of exceptional UCSF postgraduate resident investigators in acquiring
rigorous clinical and translational research skills, conducting high-impact and clinically relevant research,
and launching promising research careers in cardiovascular, respiratory, or non-malignant hematologic
diseases. This application builds on a large and diverse faculty with expertise in clinical and translational
research, a strong institutional track record in multidisciplinary postgraduate research training, and an
existing, successful Resident Research Training Program developed by our Clinical and Translational
Science Institute (CTSI) that provides a strong foundation for this initiative.
Our StARR program will emphasize clinical and translational research, defined broadly to include early
translational research involving human tissues, clinical and epidemiologic investigations, population-based
science, and dissemination research to translate scientific findings into real-world settings. We have already
designed an intensive, 12-month, contiguous resident research training program that emphasizes rigorous
training in clinical and translational research methods, recognizing that many clinician scholars seeking to
pursue clinical or translational research lack formal methodologic research training. For this application, we
have worked closely with residency leaders from eight clinical departments (internal medicine, pediatrics,
anesthesia, laboratory medicine, general surgery, integrated vascular surgery, emergency medicine, and
obstetrics and gynecology) to develop a detailed plan for recruiting and selecting the most promising
resident investigators who can bring diverse clinical perspectives to cardiovascular, pulmonary, or
hematologic science. With StARR funding, we propose to enhance residents' research and career
development opportunities, cultivate their relationships with experienced faculty mentors, and guide them in
obtaining future research funding, while simultaneously fulfilling all board credentialing requirements.
In this application, we aim to: 1) recruit and train 3 outstanding clinical residents annually from a diverse set
of residency programs who have the potential to develop successful research careers in cardiovascular,
respiratory, or non-malignant hematologic diseases; 2) guide these residents in obtaining more advanced
methodological, analytic, and collaborative research skills appropriate for their level of training; 3) create and
support effective, influential, and long-lasting research mentor relationships during and after residency; 4)
integrate residents into a community of other scientists-in-training to facilitate networking and exchange of
ideas; and 5) guide residents in successfully competing for other forms of research support that will pave the
way for them to pursue long-term clinical and translational science careers.

Public health relevance
PROJECT NARRATIVE This Stimulating Access to Research in Residency program is designed to provide clinical residents with the tools, mentorship, and support necessary to conduct high-impact research at a time when their emerging patient care responsibilities may be awakening a new appreciation for the need for clinically-relevant scientific investigation. As such, it addresses the need for clinician scientists who combine first-hand perspective on the diagnosis, prevention, or treatment of heart, lung, and blood diseases with the methodologic, collaborative, and leadership skills necessary to make important scientific discoveries.